Cellular mechanisms by which Neisseria gonorrhoeae infects the female reproductive tract

Project Summary
Neisseria gonorrhoeae (GC) infect humans exclusively, primarily the genital tract, causing gonorrhea, which
remains a public health crisis due to antibiotic resistance and no vaccines. GC infect both males and females,
but women disproportionally suffer from severe complications. However, most female infections are
asymptomatic. GC can colonize the vaginocervix asymptomatically for months, which delays treatments and
allows infections to silently disseminate and ascend to the upper reproductive tract, leading to pelvic
inflammatory disease and predisposing women to infertility and ectopic pregnancy. GC infection has been
shown to induce mucosal cytokine secretion into vaginocervical secretions and in epithelial cell lines. However,
the mechanism(s) used by GC to actively colonize the cervix without triggering immune detection remains
unknown. Whether the local cytokine response plays a role in asymptomatic infection is also unclear. This
proposal aims to determine the mechanisms by which GC manipulate the initial local cytokine response to
enable asymptomatic colonization of the human cervix. Work supported by this grant has established an ex
vivo GC cervical infection model mimicking GC in vivo infection, using human cervical tissue explants. This
model gives us a unique opportunity to understand GC asymptomatic colonization at the cervix. Using this
model, we have revealed the local IL-10 induction at the cervix as a mechanism for GC to inhibit local immune
detection and promote GC colonization, which leads to our hypothesis: GC-epithelial cell interactions,
dependent on GC surface structures, result in differential localized production of pro-inflammatory epithelial
disrupting and anti-inflammatory epithelial repairing cytokines to interrupt the earliest signals of inflammation.
To pursue this hypothesis, we will combine the cervical tissue explant model with isogenic GC strains, cutting-
edge Luminex and tissue imaging technologies, and emerging spatial transcriptomic technologies. We will
characterize the initial GC-induced cytokine production in the human cervix and the role of GC surface
molecules in cytokine induction, determine how GC-induced cytokines promote asymptomatic infection in the
cervix, and investigate how GC manipulate transcriptomic programs of cervical cells to induce cytokine
production. The proposed studies will significantly advance our understanding of mechanisms underlying
asymptomatic infections of GC and other sexually transmitted infections in women, filling critical knowledge
gaps and enlightening novel ideas for designing preventatives and vaccines and understanding other
challenging women’s health issues.

Public health relevance
Project Narrative This project examines the mechanisms by which Neisseria gonorrhoeae, the causative agent of one of the most common sexually transmitted infections, evades local immune detection to establish asymptomatic infection in the female reproductive tract. The results of this project will significantly advance our understanding of how this bacterium manipulates initial local immune responses for its survival and provide new strategies to prevent the infection, addressing the threat of the emergence of antibiotic-resistant N. gonorrhoeae.